Leadership Administrative Core (LAC)

LEADERSHIP ADMINISTRATIVE CORE ABSTRACT
The mission of the Leadership Administrative Core (LAC) is to develop a community of women’s health and
sex/gender science in Atlanta, Georgia and to transform Emory University into a Center of Excellence whose
investigators routinely include consideration of sex differences as an essential element of all research. The
LAC will be the scientific and administrative heart of the Emory SCORE with responsibility for providing overall
leadership, allocating resources, influencing research priorities, and providing logistical support to expand
women’s health research and sex/gender science locally, regionally and nationally. Through a multi-pronged
annual strategic planning process and the promotion of collaborative teamwork across the SCORE-supported
Cores and Projects, the LAC will lead Emory’s efforts to increase the recognition, support and dissemination of
research on sex differences at Emory and beyond. The LAC will receive guidance from three advisory groups -
- the SCORE internal and external advisory boards and the SCORE community liaison council -- when
developing the SCORE strategic plan and evaluating SCORE activities. The LAC leadership have a long
history of working together collaboratively and are already integrated into Emory-based programs that will help
to enable, amplify, and disseminate SCORE research and to enable and advertise SCORE education and
training activities. The success of the proposed LAC stems from the formidable institutional, environment, and
leadership support provided by Emory University and its faculty. The specific activities of the LAC will include
a) Provide administrative and executive leadership for the SCORE at Emory University; b) Furnish SCORE
Cores and Research Projects with necessary resources to accomplish their aims; c) Ensure continued
institutional and community support for SCORE activities; d) Certify SCORE’s compliance with institutional,
federal, and NIH policies, procedures, and requirements; and e) Foster information sharing about sex/gender
science among researchers and the larger community.

Public health relevance
LEADERSHIP ADMINISTRATIVE CORE PROJECT NARRATIVE: Evaluation of sex differences in research is critical for appropriate translation and implementation of research findings. The Leadership Administrative Core (LAC) will be scientific and administrative leadership for the SCORE, allocating resources, influencing research priorities, and providing logistical support to expand women's health research and sex/gender science at Emory, regionally and nationally. The LAC mission is to develop a scientific community centered around women's health and sex/gender research and to transform Emory into a Center of Excellence whose investigators routinely include consideration of sex as an essential biological variable in all research.